Nutritional immunity during Salmonella infection

SUMMARY
Non-typhoidal Salmonella (NTS) causes 100 million infections per year worldwide. The pathogen infects the
gastrointestinal tract, where it triggers intestinal inflammation. Essential to NTS pathogenesis is the ability to
evade host responses and compete with the gut microbiota. Research in my laboratory has contributed to
elucidating the duality of the mucosal response to Salmonella enterica serovar Typhimurium (STm), a highly
prevalent NTS serovar. Particularly, we have shown that STm evades sequestration of essential metal nutrients,
a process known as “nutritional immunity”, to thrive in the inflamed gut and compete with the microbiota. We
discovered: (i) key host factors that modulate nutritional immunity in the inflamed gut, including the cytokine
interleukin-22 (IL-22) and the antimicrobial proteins lipocalin-2 and calprotectin; (ii) several mechanisms and
virulence factors that enable STm to overcome metal nutrient sequestration in the inflamed gut. We also
discovered that, during colitis, the probiotic bacterium Escherichia coli Nissle 1917 (EcN) competes with STm
for iron and zinc via multiple mechanisms, including expression of high affinity iron and zinc acquisition systems,
and secretion of small antimicrobial molecules termed microcins. Building on this prior work, the primary objective
of this application is to continue to investigate host-microbe and microbe-microbe interaction in the inflamed gut,
a complex environment with unique nutritional challenges for both pathogens and the microbiota. We will
continue to investigate the role of microcins and zinc acquisition systems in the inflamed gut, and we will expand
to elucidating the role of secondary bile acids, including newly discovered microbial conjugated bile acids, in
modulating nutritional immunity. Our central hypothesis is that the host inflammatory response changes the
nutritional and metabolic landscape of the gut, triggering an environment that favors the bloom of
Enterobacteriaceae and promotes microbial competition. In Aim 1, we will elucidate mechanisms of competition
for metal nutrients in the inflamed gut between Salmonella, E. coli Nissle, and the gut microbiota. In Aim 2, we
will evaluate the impact of Salmonella infection on bile acid pool composition, and the impact of these changes
on nutritional immunity. Understanding the host and microbial factors that modulate host immunity, together with
the mechanisms by which STm thrives in this environment, is essential for developing new approaches to limit
STm replication in the inflamed gut.

Public health relevance
NARRATIVE Non-typhoidal Salmonella infects the gastrointestinal tract and is a leading cause of morbidity and mortality worldwide. We aim to understand how Salmonella thrives in the inflamed gut, and how beneficial microbes can outcompete Salmonella in this hostile environment. Our long-term goal is to develop new strategies to limit Salmonella infection.